Mediators of Muscle Rejuvenation with Aging

Project Summary
Tissue function declines with age which has deleterious effects that can be mitigated by exercise. The
molecular causes of functional decline with age and the extent to which tissue aging can be mitigated by
exercise is unclear. The reversal of cells to a younger epigenetic and phenotypic age is controlled by
Yamanaka factors (OCT3/4, SOX2, KLF4, and MYC, or “OKSM”). In skeletal muscle, the most voluminous
tissue in the body, MYC is the only Yamanaka factor induced by exercise. MYC also becomes less responsive
to exercise with advancing age. The purpose of the funded R01 is to examine the role that MYC plays in
skeletal muscle functional, metabolic, cellular, and molecular plasticity throughout the lifespan. To answer our
research questions, we developed a mouse model that allows for pulsatile control of MYC specifically in
skeletal muscle fibers simultaneous with fluorescent labeling of muscle fiber nuclei (myonuclei) for purification
and downstream analyses. We also developed a novel murine model of voluntary exercise for aged mice. We
will perform: 1) functional, bioenergetic, and cellular analyses, 2) single myonuclear RNA-sequencing, and 3)
global DNA methylation and methylation clock analyses in myonuclei after weekly pulsatile MYC induction and
exercise throughout the lifespan. We hypothesize that MYC induction in muscle will mimic functional and
cellular aspects of exercise adaptation throughout the lifespan and amplify the effects of exercise training.
MYC will mediate youthfulness at several molecular levels, including biological aging determined by DNA
methylation “clock” age. Furthemore, we hypothesize that MYC induction late in life is sufficient to reverse
molecular and cellular aspects of muscle aging. Our experiments will provide fundamental information on the
role of MYC in skeletal muscle and its capacity for epigenetic and transcriptional age reversal in myonuclei. We
expect that our innovative approaches and comprehensive hypothesis-driven -omics analyses will serve as a
foundation for understanding skeletal muscle mass regulation with aging, and provide new directions for
exploring what mediates the age-defying effects of exercise. If the K02 proposal is funded, it would: 1) add
collaboration and expertise to include additional hallmarks of aging for the R01 project by measuring
proteostatic mechanisms and myonuclear DNA turnover, 2) facilitate collaboration with Dr. Benjamin Miller who
is focused on Geroscience research in skeletal muscle and is an expert on isotopic labeling and proteostasis,
3) increase time for grant writing and mentorship, and 4) encourage immersion in the Geroscience field to
improve healthspan through targeting skeletal muscle myonuclei.

Public health relevance
Project Narrative Exercise is a powerful stimulus for attenuating age-associated tissue decline, but the molecular mechanisms behind this are incompletely understood. Using muscle functional, bioenergetic, and cellular measures as well as nucleus-specific DNA methylation aging analysis and single myonuclear RNA-sequencing, the purpose of the R01 proposal is to provide fundamental information on what mediates skeletal muscle molecular reprogramming toward youthfulness, and the K02 will protect time for this research and other collaborative activities. Combined with a conditional and inducible muscle-specific gene expression model and a new murine exercise training approach, we hypothesize that the exercise-responsive Yamanaka factor MYC plays a central role in promoting a youthful tissue profile during aging and can be leveraged to improve muscle health throughout the lifespan.